Circadian and Sleep Programming in Angelman Syndrome Mouse Models

Project Summary/Abstract: Circadian (daily) rhythms regulate myriad behavioral and molecular processes including locomotor activity, sleep timing, feeding behavior, metabolism, and gene expression. These biological clocks are a crucial component of human health, and improper functioning of this system is associated with sleep/wake disorders, metabolic syndrome, and obesity. The current molecular model for the circadian clock mechanism comprises autoregulatory transcriptional & translational feedback loops of central clock genes that necessitate rhythmic synthesis and degradation of clock gene products. We have found that the effective gene dosage of the Ube3a gene that encodes an ubiquitin ligase (involved in protein degradation) regulates fundamental properties of the circadian clock system in mammals. The expression level of the Ube3a gene is crucial for normal neurodevelopment. For example, reduced dosage of Ube3a leads to Angelman Syndrome (AS) and increased dosage/activity can result in autism. Therefore, the level of expression of Ube3a is critical for normal cognitive development, and the thesis of this project is that balanced expression of Ube3a is key for stable circadian rhythmicity as well. AS is a disorder characterized by cognitive/developmental delays, speech impairment, sleep disorders, and seizures. The paternal allele of Ube3a is imprinted (silenced) in neurons, and most cases of AS result from a deletion of the maternal Ube3a allele that further downregulates Ube3a in neurons. Mouse models have been generated that have (i) a deletion of the maternal Ube3a allele (model of AS), and (ii) extra copies of Ube3a (model of autism); these models enable tests of our hypothesis, which is that Ube3a expression affects the plasticity of circadian rhythms and that environmental, genetic, and/or pharmacological treatments can be identified that compensate for the loss of Ube3a expression. This hypothesis will be tested by manipulating environmental, genetic, and developmental conditions to affect the circadian system in mouse models of AS. Specific pharmacological treatments will be tested for their potential in reversing the circadian phenotypes of AS models to use as a basis for identifying a biomarker to be used with human subjects. Clock proteins will be identified as molecular targets of Ube3a-mediated ubiquitination. Finally, an Ube3a overexpressing mouse model will be tested to determine if Ube3a overexpression has reciprocal effects to the Ube3a null of AS models. This project represents a novel area of investigation that has the potential to enhance health-related research; its overall significance is (i) to elucidate the role of ubiquitination and imprinting in the circadian mechanism, and (ii) to identify treatments that ameliorate the circadian disorders of Ube3a imprinting in mouse models. The answers to these questions will help us to understand fundamental circadian organization and plasticity in this fascinating—and potentially clinically relevant—example of gene X environment interaction.

Public health relevance
Project Narrative: RELEVANCE TO PUBLIC HEALTH: Biological clocks have been found to be crucial for mental and physical health; depression, sleep disturbances, cancer, metabolic disorders, and cardiovascular disease are associated with the disruption of these timing systems by genetic and/or environmental disturbance (i.e., by shiftwork or "jet-lag"). Understanding the role of ubiquitination in the regulation of circadian clock proteins will provide critical information about the plasticity of the clock mechanism that may be used to allow the proper phasing of sleep so as to enhance the health and well-being of humans suffering from neurodevelopmental disorders and their families.